Administratice Core

The responsibility ofthe Administrative Core will be to ensure that the program project grant operates smoothly. The Core is directed by Dr. Hecht as Principal Investigator of the program project grant. Four committees have been organized to assist with the successful operation of the Administrative Core. They are the Steering Committee, the Internal Advisory Committee, the External Advisory Committee, and the Results Dissemination and Policy Committee. The Steering Committee will meet monthly and will discuss and evaluate progress in all projects and cores, and plan new directions as necessary. It will establish priorities, coordinate data, and manage reports, publications, and problem areas. The Internal Advisory Committee will meet annually and will be responsible for keeping other units ofthe participating universities informed of progress as necessary and for solving any administrative problems regarding the relationship of this research to that in other university units. The External Advisory Committee will meet annually and will be responsible for advising program project members on their research and helping in the interpretation of data and planning of new studies as necessary. The Results Dissemination and Policy Committee will serve in an advisory capacity to the program project regarding the use of culturally appropriate approaches to build support from the community while maintaining scientific integrity of the studies. The Administrative Core also will be responsible for determining that all studies involving samples from human subjects are approved by the University of Minnesota Research Subjects Protection Programs Institutional Review Board Human Subjects Committee and the Masonic Cancer Center Protocol Review Committee, as well as the appropriate bodies at the University of Southern California and the University of Hawaii.

Public health relevance
Lung cancer is the leading cause of cancer death in the world, killing 3500 people every day. The results of this program project grant research, if successful, will provide critical new insights for lung cancer prevention. The Administrative Core will ensure that this research runs smoothly and is well integrated both within the project and externally.